Development of GB13 for the Treatment of Pediatric Diffuse Intrinsic Pontine Glioma

PROJECT SUMMARY/ABSTRACT
Diffuse Intrinsic Pontine Glioma (DIPG) is a rare, pediatric tumor typically arising in the ventral pons of the
brainstem with no effective treatment options. Every year approximately 400 children in the US are diagnosed
with this disease. Physical location, the blood-brain barrier and limited molecular understanding of DIPG have
played key roles in the inability to improve disease prognosis. Currently, the only treatment option is radiation
therapy, however, there is very little tumor response and this intervention is limited primarily to palliation. New
treatment options that improve the radiation response will significantly advance this therapeutic durability.
One mechanism to overcome drug delivery challenges created by the blood-brain barrier is through
convection enhanced delivery (CED), which administers treatments directly into tumors and increases treatment
efficacy. As such, this proposal combines a novel targeted therapy with CED to dramatically advance treatment
response for DIPG patients.
IL13R2 is a cancer-specific receptor expressed on several cancer types, including DIPG, glioblastoma and
adrenal cortical carcinoma, and functions to bypass the apoptosis-inducing pathway mediated by ubiquitously
expressed IL13R1 and IL13. The tumor cell restriction also provides an opportunity to specifically target
cancer cells by leveraging IL13/receptor association. As such, Targepeutics has developed a mutated IL13-
derived toxin, called GB13, that preferentially binds to IL13R2 and possesses a Pseudomonas exotoxin moiety
to kill targeted cells.
The three aims of this project independently work to develop the clinical advancement of GB13 for the
treatment of DIPG by; 1) determining the in vivo efficacy of GB13 for IL13R2-positive mouse models of
DIPG when administered via CED, 2) analyzing the ability of GB13 to increase sensitivity of DIPG cells to
radiation, and 3) correlating RNA and protein expression of IL13R2 for biomarker-based patient inclusion.
The expected results of this proposal will provide necessary proof-of-concept data to support an IND
submission for a phase I trial.

Public health relevance
PROJECT NARRATIVE Diffuse Intrinsic Pontine Glioma is a rare, pediatric cancer that arises in the brainstem and is a uniformly deadly diagnosis. IL13R2 is expressed specifically in these glioma cancer cells but not surrounding brain tissue and can be targeted by the exotoxin therapeutic, GB13. This proposal advances the clinical development of GB13 by understanding the ability of GB13 to kill IL13R2-positive pediatric glioma cells, determining GB13 radiosensitizing capabilities and improving the method of clinical IL13R2 detection in patient biopsies for clinical trial patient inclusion criteria.